Intervention Core - Improving Provider Announcement Communication Training (IMPACT)

ABSTRACT – Intervention Core
The Intervention Core will support the proposed Program Project, “Improving Provider Announcement
Communication Training (IMPACT)” with the goal of improving HPV vaccination in healthcare systems. The
Intervention Core will synthesize project-specific findings regarding the implementation and effectiveness of
standing orders support (Project 1), financial incentives (Project 2), and clinical champions (Project 3) into the
Announcement Approach Training (AAT) Intervention Package. AAT is a brief communication workshop that
helps primary care teams improve the way they recommend HPV vaccine and address parents' concerns. In a
prior randomized clinical trial, AAT increased HPV vaccine coverage by 5 percentage points over the control
within just 3 months. The proposed Program Project seeks to amplify AAT's impact by combining it with the
interventions to be tested in Projects 1-3. The Program Project will then compare the population impact and
cost-effectiveness of these interventions, including in rural areas (Project 4). The Intervention Core will support
the four research projects in the P01 to maximize the quality and comparability of AAT interventions delivered
and evaluated over the 5-year study period. Aim 1 is to convene a Clinical Advisory Board to provide
projects with multi-disciplinary implementation support. Our board includes leaders in pediatrics, family
medicine, nursing, quality improvement, and patient and family advocacy. Through quarterly meetings, the
board will support the development of intervention materials, the recruitment and retention of clinical sites, and
the interpretation and dissemination of study findings. Aim 2 is to prepare AAT facilitators and training
materials for intervention delivery. To achieve the highest-quality interventions, we will centralize (1) the
training of the facilitators who will deliver our AAT workshops to primary care teams and (2) the preparation of
intervention materials. Aim 3 is to harmonize assessment of implementation measures, including cost.
The Intervention Core will monitor the quality of implementation data collected in Projects 1-3 to ensure
timeliness, completeness, and accuracy. This quality monitoring will support the successful completion of
Project 4's cost-effectiveness analyses and other information for the AAT Intervention Package. Aim 4 is to
facilitate the national dissemination of study findings and intervention materials. Collaborating with
Projects 1-4, the Intervention Core will disseminate study deliverables to audiences in academia, clinical
practice, and public health. Most notably, the Core will lead the production of the AAT Intervention
Package for improving HPV vaccination in healthcare systems. In sum, the Intervention Core will be
instrumental to the Program Project's goals of improving primary care teams' communication, increasing HPV
vaccine uptake, and ensuring that today's youth have the highest level of protection against future HPV
cancers. The Intervention Core addresses the IMPACT Program Project theme by building capacity for HPV
vaccine communication interventions among primary care teams in healthcare systems.

Public health relevance
NARRATIVE – Intervention Core The Intervention Core will support the efforts of 4 research projects to conduct high-quality evaluations of Announcement Approach Training interventions. We will accomplish this goal by coordinating clinical expertise, preparing training materials and facilitators, harmonizing key measures, and sharing study products.